Polygenic Risk Scores for Alzheimer's Disease in Hispanic/Latinx Populations

ABSTRACT. Late-onset Alzheimer's disease (LOAD) is the most common neurodegenerative disease, but its
causes remain largely unclear. LOAD's large missing heritability has been attributed, at least partially, to
mechanisms not currently investigated by traditional “single-locus” approaches. To this end, we aim to study
the role of Polygenic risk scores (PRS), which capture sparse genetic information by summing up multiple
risk loci across the genome, providing an individual genetic risk profile. Numerous studies have confirmed that
LOAD is enriched with a polygenic component. Most of PRS have been developed in European-descend
populations and no ancestry-specific PRS for LOAD have been developed in Hispanic/Latinx (HL).
Furthermore, most PRS rely on common genetic variants (minor allele frequency ≥1%), neglecting the
contribution of rare variants which have been shown to be critical in LOAD pathogenesis. To this end, we will
generate traditional and innovative PRS leveraging large HL cohorts available at Columbia University, employing
common and rare variants. Because linkage disequilibrium between common and rare variants is low, we
hypothesize that these two PRS will be independent in terms of disease prediction and patient risk stratification.
For common variants PRS (cvPRS), we have strong preliminary data in Caribbean Hispanics that culminated in
a recent publication from our group. In addition, we will employ a new approach developed by our group, RV-
EXCALIBER, which combines rare variant burden over a large number of genes into predictive rare variant
polygenic risk score (rvPRS). Employing HL is particularly indicated for rvGRS because 1) they are enriched
with rare variants and 2) have higher incidence and prevalence of LOAD compared to European descend
populations.
We will study three HL populations that exhibit different proportions of European, African and Amerindian
ancestry: 1) Caribbean Hispanics 2) Mexicans and 3) Peruvians. These cohorts are deeply phenotyped for
LOAD, have GWAS data and whole-exome/genome sequencing data (WGS) and plasma AD-biomarkers
available for a sub-sample. We will first (Aim 1) generate a cvPRSs using common variants associated with
LOAD within each Hispanic cohort. We will also generate an alternative local ancestry-weighted PRS and test
the transferability of each cvPRS across HL cohorts and finally will construct a trans-ancestry PRS. Then (Aim
2) we will generate rvPRSs for those individuals with WGS and compare the performances of the two PRSs. We
will also test a model that combine cvPRS and rvPRS. Finally, we will validate these new PRSs from Aim 1 and
Aim 2 employing LOAD-related endophenotypes and explore a multi-trait PRS approach (Aim 3).

Public health relevance
NARRATIVE. Polygenic risk scores (PRS) have the potential to identify individual's disease risk by combining sparse information distributed across a large number of genetic variants: so far, most of PRS have been generated in non-Hispanic Whites populations. We aim to generate traditional and innovative PRS for late-onset Alzheimer's disease (LOAD) in Hispanic/Latinx individuals (HL), one of the fastest growing minority population in the US and characterized by higher incidence and prevalence of LOAD. In this application, we will generate common- variants and rare-variants PRS in three HL populations (Caribbean Hispanics, Mexicans, and Peruvians) leveraging large sample sizes (N>26,000) and available GWAS, sequencing and endophenotypes (clinical, neuroimaging and blood AD-biomarkers).